Implementation Solutions, and Evaluation Core

Abstract
Evaluation and dissemination of evidence-based solutions to mitigate the health effects of heat stress can curb the anticipated increases in heat-related morbidity and mortality. However, little research to date has considered how to evaluate and disseminate locally appropriate solutions across global contexts. Doing so requires careful attention to the local context and resources, how the interventions are delivered and received by the community, and the types of quantitative data and dissemination products most valuable to decision-makers. Adopting an implementation science (IS) perspective, which has scarcely been applied in HEW analysis, can assist us in designing and evaluating solutions in a manner that increases the likelihood they will be spread and utilized. The Implementation, Solutions and Evaluation Core (ISE) of C-EARTH will conduct rigorous evaluations of the impacts of the cooling solutions under study at each project site (Boston, Madagascar, and South Africa) and will advance the translation of these solutions into policy through the design of responsive dissemination products developed using an innovative approach to participatory IS for HEW. Specifically, the ISE aims to provide the following services and supports at each project site: (1) conduct robust quantitative and qualitative data analyses to assess the effectiveness and implementation of cooling solutions and community engagement; (2) use participatory approaches to support policy translation of solutions (including economic evaluations and co-design of dissemination products) at local, regional, and national levels; and (3) co-develop and offer capacity-building interventions for researchers and local leaders to support a “designing for dissemination” approach to solution generation. To ensure success of these aims, we have assembled a team with rich expertise in implementation science, community-engaged research, biostatistics, environmental health, and economic evaluation, and we will leverage long-standing partnerships that C-EARTH’s leaders have with community leaders and policy-makers in the three settings. The work of the ISE will also be closely integrated and synergistic with the projects and the CEC. In addition to providing essential supports to enhance the rigor and impact of the work undertaken by C-EARTH, the ISE will serve as a pioneering model of applying participatory IS approaches to advance HEW adaptation. Broader application of such approaches will facilitate transformational policy change to reduce the health risks of extreme heat.

Public health relevance
Extreme heat events are an increasing threat to public health, causing illness, death, and disruptions to food and water supplies. This project will develop and test practical, community based solutions to reduce the health risks of heat stress. By partnering with local organizations and adapting interventions to community needs, this research will provide evidence on effective and scalable strategies to prevent heat-related health problems. The results will guide public health action and policy to better protect US populations from extreme heat now and in the future.